Motor sequences and basal ganglia-cortical circuits

The fluid, seemingly effortless execution of sequences of movements is a ubiquitous feature of everyday motor
behavior. Ample evidence for the importance of this ability comes from the common human diseases
(Parkinson's disease, in particular) in which sequential skills are especially impaired. Long-term motor
sequencing skills are formed, most likely, through the cooperation of parallel cortical-sub-cortical circuits
involving associative, premotor, and motor regions of the brain. Recent evidence suggests that for each of these
brain circuits, the sub-cortical loop through the basal ganglia (BG) contributes selectively to reinforcement-driven
modulation of thalamo-cortical plasticity while cortex is well-suited as a site for long-term retention and efficient
recall of well-practiced skills. These findings lead to the hypotheses that BG loops play central roles in the
acquisition of sequence information whereas the anatomically-connected cortical areas are more important for
the storage and use of already-learned information. The specific aims (SAs) of this proposal will test that general
hypothesis by using non-human primates: (1) To determine if neurons in the globus pallidus interna (GPi, a
primary BG output nucleus) preferentially encode sequence task information during learning and the production
of recently learned sequences. Cortical neurons are predicted to not show a preference for recently learned
sequences. (2) To test if intact BG circuits are necessary primarily for the learning and production of recently-
learned sequences. Cortical circuits, in contrast, are predicted to be necessary even for well-learned sequences.
Associative loops through cortex and BG may play greater roles in the fast acquisition and flexible recall of goal-
directed sequence information. The premotor and motor loop circuits may mediate slow acquisition of habit-like
effector-specific representations. We will infer the circuit membership of individual GPi neurons by stimulating
different cortical areas and observing the orthodromic inhibitory effects. Animals will perform a discrete sequence
production task alternating in blocks between random, novel-to-familiar and over-trained sequences. SA1 will
test if neuronal encoding of task information in associative, premotor, and motor circuits reflects the predicted
divergent roles for BG- and cortical-components of these circuits. SA2 will determine if interruptions of BG output
(i.e., GPi inactivation or lesion) selectively impair the learning or recall of recently learned sequences.
Inactivations of cortex, in contrast, are predicted to also disrupt the recall of well-learned sequences. Results
from these experiments will aid in understanding the physiological basis for normal and impaired sequential
behavior in humans.

Public health relevance
The proposed experiments explore the brain circuits that support our seemingly effortless ability to learn and perform sequences of movements with grace and efficiency. Dysfunction in the same brain circuits is thought to cause some of the symptoms seen in common neurologic disorders such as Parkinson’s disease and dystonia. These experiments will elucidate the relationship between normal functions of the basal ganglia and the clinical signs associated with basal ganglia dysfunction.